Uncovering DIP-α signaling pathways underlying circuit assembly

PROJECT SUMMARY / ABSTRACT
All animal behaviors and cognition require precise assembly of neural circuits. Despite a highly complex
environment in the central nervous system, neurons faithfully recognize their precise partners and establish
synaptic connections. Precise connectivity has been well demonstrated across many organisms, but the
mechanisms underlying this specificity remain unclear. Cell surfaces proteins (CSPs) have been implicated in
establishing correct connectivity, specifically by serving as “identification tags”. In Drosophila, two CSP
subfamilies of the immunoglobulin superfamily (IgSF), the Dprs and DIPs, have garnered significant attention
due to their multifaceted roles in nervous system development. The 32 members of the Dpr and DIP
subfamilies are GPI-anchored, and several interacting pairs were demonstrated to have roles in instructing
connectivity in several circuits. For example, DIP-α is required for instructing connectivity between motor
neurons (MNs) and muscles in the motor system and between interneurons (INs) in the visual circuit. Our
preliminary data suggests that DIP-α localizes to the dendrites of MNs as well, suggesting a potential role in
IN-MN recognition. Despite their fundamental roles in various circuits, the signaling mechanism(s) underlying
DIP/Dpr functions remains unclear. This proposal will test two non-mutually exclusive hypotheses: Aim 1) DIPs
and Dprs instruct IN-MN connectivity and Aim 2) DIPs and Dprs interact with other CSP co-receptors to
transduce cellular signals. I will focus on DIP-α because of its implications in connectivity, cell survival, and
synaptic development; however, I hypothesize that some signaling components will be shared between
Dpr/DIP members. In Aim 1, I will reconstruct MN dendrite morphology and synaptic connectivity between a
MN and its presynaptic INs. I will determine if known DIP-α interactors, Dpr6/10, are required and investigate
the functional outcome of disrupting DIP-α-dependent connectivity. In Aim 2, I will use proximity labeling to
uncover candidate DIP-α co-receptors in an unbiased manner, and I will validate them biochemically and
genetically. This proposal will combine interdisciplinary and innovative approaches, including optogenetics,
electrophysiology, biochemistry, microscopy, proteomics, and bioinformatics to elucidate fundamental
mechanisms underlying synaptic connectivity. The proposed work will address significant knowledge gaps in
central motor circuit connectivity and signaling mechanisms of GPI-anchored proteins. The vertebrate
orthologs of DIPs/Dprs, the IgLONs, are also GPI-anchored and are associated with various diseases,
including Alzheimer’s disease and autism spectrum disorder. Thus, our proposed study may also contribute to
our understanding of the molecular processes disrupted in specific neurological disorders.

Public health relevance
PROJECT NARRATIVE Establishing specific synaptic connections is critical for proper neural circuit function, and alterations in connectivity have been linked to neurological diseases such as Alzheimer’s and Parkinson’s diseases. This proposal will investigate how two subfamilies of cell surface proteins, the Dprs and DIPs, instruct specific connectivity in Drosophila central motor circuits. This study will also examine the signaling mechanisms underlying Dpr and DIP interactions, and potentially provide new signaling insights into their vertebrate orthologs, the IgLONs, which are associated with various neurological diseases.